CORE--BIOSTATISTICS

The Biostatistics Core Component of this Program Project Grant will provide overall guidance on study design, data processing and analysis, and statistical aspects of this research proposal in Drug Discovery. Collaborative research relationships already exist between staff members of the Biostatistics Core and the Principal Investigators of the various projects proposed. Biostatistical support appropriate to the needs of each of the individual research projects and Cores in this Program Project Grant will be provided by consultation with the respective Principal Investigators and Core Leaders.